Administration

Summary
Scientific and administrative leadership and effective program project management of the HIVRAD is the goal of
Core A. The core will oversee scientific progress relative to project aims and milestones and lead scientific efforts
in conjunction with the Executive Committee and Scientific Advisory Board. It will coordinate financial
management, research program management, regulatory compliance and reporting functions. In addition to
coordinating these activities, the Administrative Core will be responsible for promoting and documenting all
aspects of scientific, IACUC and financial regulatory compliance at Penn and subcontracting institutions. Staff
on this core are located within the administrative offices of Dr. Shaw, thus taking advantage of a highly
experienced and integrated management team. The University of Pennsylvania provides infrastructure support
for administration, information technology, IACUC oversight and compliance, and human resources, and also
provides dedicated pre- and post-award units to facilitate administrative and fiduciary compliance. Penn will
provide this support for the HIVRAD. A highly functional administrative core will contribute to and facilitate the
successful advancement of the proposed science. Specific aims of Core A are to: (i) provide scientific and
administrative leadership and program coordination; (ii) ensure timely financial accounting and reporting; (iii)
ensure regulatory compliance with all institutional and federal research guidelines; and (iv) develop and
implement an HIVRAD communications and data sharing plan.